Information Technology Services and Support (ITSS)

DOI shall provide support for a range of information technology support requirements for DCCPS, including strategic planning, project management, enterprise architecture planning, development, operation and maintenance of the information systems and development, operation, maintenance of informatics projects.